WU-SN-TMC Data Analysis Core

Data Analysis Core Summary/Abstract
Our group has a well-established history of large-scale omics and imaging data management, processing,
analysis, and interpretation in the context of consortium projects. We have built, used, and maintained data
warehouses and the associated tracking, meta-data, and QC machinery for specimens and raw data and have
developed a large number of computational tools for processing, analyzing, and interpreting such data. The
primary mission of the Data Analysis Core at the Washington University Cellular Senescence Network Tissue
Mapping Center (WU-SN-TMC) will take place along 4 primary dimensions: 1) providing data support to the
Biospecimen and Biological Analysis Cores, 2) processing raw assay data from the Biological Analysis Core
and marrying these with data from other SN-TMCs using cutting-edge informatics pipeline and integrated
approaches, 3) applying processed data to build organ-specific cellular senescence atlases, with a focus on
differences/evolution among demographic groups (especially by age) and within the individual (between
organs and longitudinally), and 4) finally managing delivery of data and research products to the Consortium
Organization and Data Coordinating Center (CODCC) and coordinating further activities toward amalgamation
of findings across the SenNet project. Data Analysis Core will promote cooperation through development of
common formats and interoperable tools for advanced omics and imaging technologies within the SenNet
program, harmonize tools in larger, scalable, user-friendly pipelines and distribute tools to the larger scientific
community under open-source licensing, develop senescence signatures and models using integrated data,
and investigate how nascent technologies will be brought into the research infrastructure to improve processes
and results for senescence research. In conclusion, Data Analysis Core will be a crucial cog within WU-SN-
TMC and serve as a strong link between WU-SN-TMC, CODCC, and other TMCs within SenNet.